Neuromuscular Intervention Targeted to Mechanisms of ACL Load in Female Athletes

PROJECT SUMMARY
The overall goal of this project is to prevent risk of second anterior cruciate ligament (ACL) injury in vulnerable
populations, which consist of young, active men, women, girls and boys. Specifically, we propose to 1) stratify
patients into risk groups for second ACL injury, 2) determine the effects of differential treatment on
biomechanical measures of ACL injury risk and return to sport readiness after reconstruction (ACLR).
Additionally, we will begin the development of a clinical algorithm that will classify patient risk for second ACL
injury to facilitate the translation of findings from the laboratory into the clinic. Differential treatment will include
a home only program, a standard clinical rehabilitation program, and a novel targeted neuromuscular training
program designed to augment core and hip strength as well as promote optimum, low risk movement
strategies in both lower extremities. Highly active men and women between the ages of 14 ≥ 24 years who
have sustained an acute, isolated primary ACL injury will be recruited for study participation. As patients enter
their final phase of rehabilitation after surgery they will undergo testing that includes self-reported function,
performance of drop jumps, hop testing, strength assessment, and balance assessment. After testing, patients
will be randomized into one of the three intervention groups for a six-week, twelve-session training program.
After completion of training the patients will repeat the same battery of tests. To determine relative risk for
second ACL injury, cluster-analysis statistical testing will be performed. Differences between risk-groups will
be validated using the frontal plane hip and knee motions, which will be used as surrogates for ACL injury.
Repeated measures ANOVA testing will be conducted to identify differences before and after testing to
determine the effectiveness of each intervention program on clinical performance and biomechanical
measures. Results from this proposed work will allow us to prospectively identify high risk patients who are the
most appropriate recipients of enhanced treatment, including targeted neuromuscular training, which may
reduce second ACL risk. Patients with lower-risk for second ACL injury may achieve optimum benefits from
less intensive intervention. Thus, differential interventions may reduce the risk of a subsequent injury, enhance
the quality of life for a significant cohort of young adults, and yield a more efficacious delivery of health care
resources after ACLR.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to reduce risk of second anterior cruciate ligament (ACL) injury in vulnerable populations (active athletes between 14 ≥ 24 years old) through the identification of relative injury risk groups based on subject-specific movement patterns prior to second injury, as well as through the determination of effect for differential rehabilitation protocols following initial ACL reconstruction and prior to return to sport. As nearly one-third of athletes who have a primary ACL injury and return to sport will experience a secondary injury, results from the proposed work will allow us to prospectively identify high risk patients who are the most appropriate recipients of enhanced treatment, including targeted training, which may reduce the risk of second ACL injury. Secondary ACL injury has the potential to end athletic careers, promote the development of osteoarthritis, and have debilitating effects on quality of life. Hence, the information gathered in this investigation will offer ACL injured athletes the optimal potential to reduce or potentially prevent these negative health effects before they are initiated.